Antibody & Phage Display Shared Resource

ANTIBODY & PHAGE DISPLAY SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The Antibody & Phage Display Shared Resource offers a variety of cutting-edge technologies to develop
antibodies for use as key research reagents. The Shared Resource is led by Faculty Head Adrian Krainer, Ph.D,
and Director Johannes Yeh, Ph.D. The Shared Resource collaborates with Cancer Center members to address
fundamental and compelling questions in cancer biology, in research areas including: (1) The understanding of
the tumor microenvironment; (2) The discovery of surface biomarkers and their differential expression during
tumorigenesis; and (3) Receptor signaling in cancer. Shared Resource staff work closely with scientists to select
the best approach for their experimental needs, and specialized screens are developed in close coodination with
individual scientists. The Shared Resource also tests and implements new techniques, reagents, and assay
improvements related to the different stages of antibody production. Technologies currently available in the
Shared Resource include hybridoma development by fusion of rodent spleen cells with immortalized cell lines,
generation of nanobodies from immunized alpacas, and direct cloning of the VH-VL domains from B cells from
immunized rodents or alpacas into expression plasmids. Yeast or phage display techniques are used to optimize
the binding affinities of antibodies identified after the first round of immunization and selection. A library of
hybridomas generated in the Shared Resource is maintained, and staff will produce and purify antibodies from
these lines on request. In the last funding period this Shared Resouce was used by twelve Cancer Center
members (32%), and has contributed towards seven publications by members. Novel antibodies have generated
reagents that have been used for genomics (e.g., ChIP), cell separation (e.g., FACS), and single-cell analysis.
Finally, recently developed antibodies are currently being investigated for potential diagnostic or therapeutic
applications by members, and are thus playing an essential role in cancer programs at CSHL.

Public health relevance
ANTIBODY & PHAGE DISPLAY SHARED RESOURCE – PROJECT NARRATIVE Not required per PAR-20-043